Mechanistic and pharmacologic studies of selective mithramycin analogues targeting EWS-FLI1 in Ewing sarcoma

Ewing sarcoma family of tumors (ESFT) is a family of resilient devastating cancers of bone and soft tissue
affecting primarily children and young adults. Current highly cytotoxic combination therapy of five drugs provides
only 30% overall survival. The aberrant transcription factor EWS-FLI1 present only in tumor cells is the oncogenic
driver of EWS. However, transcription factors were believed to be “undruggable”, until a recent NCI screening
found mithramycin (MTM) to act as a potent EWS-FLI1 antagonist. MTM has proven to be too toxic with a narrow
therapeutic window and poor pharmacokinetic (PK) properties. Here we propose mechanistic and pharmacology
studies of novel MTM analogues (MTM-SA) with significantly reduced toxicity, increased target specificity and
greatly improved PK properties. In contrast to other analogues reported elsewhere, which still suffer from poor
PK properties, the MTM-SA analogs display superior kinetics and reduced toxicity. The goal of this project is to
gain molecular insights into the mode of action of MTM via structural, biochemical and pharmacological studies
to generate a highly efficacious and selective anti-ESFT treatment. To aid synthetic efforts in Aim1 and identify
analogues with clinical potential, we will perform molecular structure-function level studies in Aim 2 to determine
how transcription factor EWS-FLI1 interacts with DNA microsatellite repeats and transcription factor Runx2 (each
a necessary interaction for oncogenesis), and how these oncogenic functions are disrupted by MTM-SA. In Aim
3 will assess the in vitro cytotoxicity and target selectivity to identify analogues that will be evaluated in
pharmacologic studies that will assess toxicity in humanized liver mice, PK and metabolism, as well as efficacy
in xenograft and PDx models of Ewing Sarcoma. The project will be carried out by a team with an established
collaboration who have extensive experience in fragment-based drug design and semi-synthetic routes of natural
products, X-ray crystallographic, biophysical and molecular biology studies, and pharmacological evaluations.
We expect that these structure-function studies will identify a lead-candidate that could enter a clinical trial for
the treatment of ESFT.

Public health relevance
Ewing sarcoma and other Ewing family tumors are poorly treatable bone and soft tissue cancers diagnosed predominantly in children and young adults. This project is relevant to public health, because it aims to develop selective chemotherapeutics to treat Ewing sarcoma through investigating oncogenic mechanisms of the causative agent of Ewing sarcoma, transcription factor EWS-FLI1. This mechanistic inquiry will be complemented by pharmacological studies and aid the development of selective anti-Ewing sarcoma therapeutics.